Training the next generation of clinical neuroscientists

This renewal proposal requests support for years 6-10 of the T32MH122394 program “Training the next
generation of clinical neuroscientists”, founded in 2020. We plan to continue to recruit 2 new postdoctoral
fellows per year, and reappoint 3 trainees each year, for a total of 5 postdoctoral slots per year, as we have
been doing since year 3 of the T32. Trainees are supported for 2-3 years, contingent on Steering Committee
evaluation of their progress prior to competitive applications for reappointment for Year 3. Our T32 is led by Dr.
René Kahn, MD, PhD, a renowned physician-scientist with an outstanding track record as an investigator and
mentor in the field of neuroimaging and treatment of schizophrenia and bipolar disorder, and multiple PIs Dr.
Antonia New, MD, and Dr. Mercedes Perez, MD, PhD, both physician-scientists with extensive mentorship and
research experience. Mount Sinai is the ideal place for this T32 program because of the strength of our
Departments of Psychiatry, Neuroscience and Genetics/Genomics, which have been among the top 10
departments nationwide in NIH funding over the past 5 years, and have a wealth of diverse mentors. There is a
focused institutional effort to support clinician-scientists and translational research.
Psychiatry is a fertile medical specialty for translational research and clinician-scientists bring a unique
perspective to research through the blend of clinical and research experiences. They are uniquely poised to
bridge the gap between basic neurobiology and clinical disease and excel as leaders in translational research
in psychiatry. Our T32 program aims to train clinician-scientists who will be able to combine clinical knowledge
and expertise with superior research in psychiatry and neuroscience. One key goal is to increase the pool of
physician-scientists, as there is high attrition after completion of clinical residency training. Our T32 program
aims to address this by helping trainees acquire research skills and pilot data to obtain a career development
(K) award. Our program will provide research protected time and coursework organized based on an Individual
Development Plan. This training, coupled with outstanding mentoring, networking opportunities, grant writing
seminars and an internal K award review process, will prepare promising clinician scientists and help
accelerate the launch of productive, independent careers in translational psychiatry research. For this renewal,
we have strengthened our curriculum in translational neuroscience by adding a track in AI, Natural Language
Processing and Computational Psychiatry. In the 4 years since its creation, 8 fellows have been appointed to
our T32 program and 4 have graduated. Our program has been highly successful in achieving the goals as
shown by the following metrics: 1) high rates of trainee success (100%, 4/4) in obtaining faculty appointments,
external grant funding, or other research-focused positions; 2) high number, quality and impact of trainee
publications (mean publications=49; mean h-index=20); 3) highly qualified and diverse trainees, 38% from
under-represented groups, 38% women and meeting our recruitment target of 50% physicians.

Public health relevance
The proposed T32 program renewal is designed to train clinician-scientists, including physicians and psychologists, and clinical PhDs to formulate original research questions on etiology, pathogenesis, course, treatment and prevention of serious mental illness. Each trainee, paired with a mentor, will formulate an individual development plan (IDP) with targeted goals for acquisition of skills, presentations, publications, gathering pilot data, and grant writing for independent research funding. We aim to help fill the dearth in clinical neuroscientists so that the recent advances in neuroscience can be translated into better care for the millions of patients with serious mental illness.